Developmental Changes in Neural Processes Underlying Inattention, Impulsivity and Regulation

DESCRIPTION: Problems with impulsivity are of major

Public health relevance
Adolescence, young adulthood and attention-deficit hyperactivity disorder (ADHD) are developmental periods and a condition associated with impulsivity and risk taking that lead to major public health problems in the form of greater self-harm, substance use disorders, higher accident rates and lower educational and occupational outcomes. This longitudinal study in teens and young adults (15-30 years of age) will identify how and when different brain processes work together toward reductions in impulsivity using a combination of brain imaging methods, behavioral measures and rating scales to look at important real world outcomes (e.g., academic and occupational success, drug use, mental health symptoms, accident rates). The long-term goals of the project are to: 1) inform our understanding of development during this critical period and 2) identify those who are at-risk due to impulsive decision-making to inform targeted prevention and intervention strategies to reduce impulsivity and improve long-term outcomes for those at-risk for harm related to their impulsive behavior.